Role of Glypicans in Trabecular Meshwork Function, IOP, and Glaucoma

PROJECT SUMMARY
Ocular hypertension (OHT) arising from impaired aqueous humor (AH) outflow through the trabecular meshwork
(TM) is a major risk factor for glaucoma (optic nerve atrophy), one of the leading causes of blindness globally.
Increased contractile activity, cell adhesive interactions, and accumulation of extracellular matrix within the TM
are well-recognized to elevate intraocular pressure (IOP), with pharmacological suppression of these cellular
attributes being proven to lower IOP in glaucoma patients. Despite these advancements, our understanding of
the prominent upstream molecular mechanisms regulating TM cell actomyosin cytoskeletal organization and cell
adhesive interactions is very limited. Therefore, filling this knowledge gap is imperative for the identification of
new class of molecular targets for development of efficacious IOP lowering agents with reduced adverse effects.
Towards this overarching goal, we recently made multiple novel observations, including 1) the
identification of molecular parallels in cell adhesive characteristics between TM cells and kidney podocytes, two
cell types which share the common functional attributes of filtration and barrier activity, 2) identification of
previously undescribed proteins increasing actin cytoskeletal contraction and crosslinking including glypican-4
(GPC4, a cell surface heparan sulfate proteoglycan) in human TM cells treated with dexamethasone (Dex), 3)
identification of GPC4 as a potentially prominent upstream molecule regulating actin cytoskeletal organization
by activating Wnt5/PCP signaling in Dex and TGF-β2 treated TM cells, 4) detection of robustly elevated levels
of GPC4 in the AH of primary open-angle glaucoma patients, 5) elevation of IOP in mice with increased
expression of human GPC4 and finally, 6) inability of active TGF-β2 to elevate IOP in GPC4 null mice.
Based on these collective new findings, we hypothesize that ocular hypertensive agent-mediated
increases in glypican (e.g. GPC4) levels in the AH outflow pathway triggers dysregulation of the Wnt and growth
factor signaling activities that in turn impair AH outflow and elevate IOP, via increased Rho GTPase activity,
actomyosin contraction, cell adhesive interactions, and the barrier activity of TM. Using human TM cells and
donor eyes, and gene targeted mouse models to test the proposed hypothesis, this study will address: 1.
Whether augmented GPC4 expression and secretion dysregulates the Wnt and related (e.g. Hedgehog and
TGF-β) signaling pathways to stimulate TM cell contractile activity and adhesion, and barrier activity in the
presence of ocular hypertensive agents. 2. Whether GPC4 induced OHT is mediated primarily by activation of
Wnt5/PCP signaling in the TM and 3. Whether increased GPC4 levels play a pathological role in POAG, and
glucocorticoid- and TGF-β2- induced ocular hypertension by dysregulating the Wnt signaling pathways.
Completion of these novel studies is expected to uncover, for the first time, the role of glypicans (e.g. GPC4) in;
a) homeostasis of IOP, b) etiology of ocular hypertension, and generate data to support c) identification of new
molecular targets for lowering IOP and enable d) development of a new ocular hypertensive mouse model.

Public health relevance
PROJECT NARRATIVE Ocular hypertension due to decreased aqueous humor drainage from the trabecular meshwork is a major but a modifiable risk factor for glaucoma, one of the leading causes of blindness worldwide. Based on our promising and novel supporting findings, this proposal will investigate whether dysregulation of the Wnt and other related signaling pathways in response to elevated levels of cell surface proteoglycans (Glypicans) plays an etiological role in inducing ocular hypertension via aberrant stimulation of trabecular meshwork contractile activity, cell adhesive interactions, and barrier activity. These studies are expected to identify the prominent upstream molecular pathways involved in ocular hypertension and support the identification of new molecular targets for the development of efficacious treatments for glaucoma.